US Ten Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases and Stroke

PROJECT SUMMARY
This proposal requests sponsorship for the 48th U.S. Ten-Day Seminar. Given the burden of cardiovascular
diseases (CVD) and stroke, it is highly appropriate to conduct professional training on epidemiology and
prevention. The goals of this proposal align with the NHLBI’s Strategic Vision which seeks to “further develop,
diversify, and sustain a scientific workforce capable of accomplishing the NHLBI’s mission.” Training of such a
workforce is a key element of the country’s readiness to address the health challenges posed by CVD and the
readiness to advance multi-component strategies that promote cardiovascular health (CVH). A prepared
workforce will need research competencies in epidemiology and biostatistics, quality of care, and policy and
environmental approaches to health promotion and disease prevention. Further, authoritative health agencies
and prominent scientists have noted an increasing need for professionals who understand methods related to
e-cohorts, large practical clinical trials, dissemination and implementation research, and big data analytics.
Scientists will also need expertise in cost-effectiveness research, epigenetics, and biomedical informatics.
This Seminar can uniquely contribute to training scientists who can integrate evidence across these fields and
translate research findings into effective and impactful policy and practice. We seek primary sponsorship from
the National Heart, Lung, and Blood Institute (NHLBI) and if we receive a meritorious score we will request co-
funding from NIDDK, NINDS, the NIH Office of Disease Prevention, and the NIH Office of Behavioral and
Social Sciences Research. Other funders/partners for the Seminar are the Centers for Disease Control and
Prevention (grant), and the American Heart Association (council budgets and in-kind).
To assure the successful conduct of the Seminar, we will continue to:
1. Attract a faculty with both the knowledge of relevant content and the personal teaching skills required for
the effective conduct of this program, with a continuing emphasis on the recruitment of faculty from
underrepresented racial/ethnic groups (currently 31% of the faculty) and female faculty members
(currently 56% of the faculty);
2. Adapt program content to maintain its relevance to the training needs of the nation for health professionals
with appropriate career interests, while maintaining a consistent central focus on the foundational methods
in cardiovascular disease epidemiology;
3. Disseminate information about this program to appropriate groups, using the most effective current
strategies for reaching underrepresented racial/ethnic groups, female candidates and historically
marginalized groups; and
4. Recruit participants from populations that have been historically marginalized by connecting with diverse
professional societies and organizations, and sustained relationships with seminar alumni.

Public health relevance
PROJECT NARRATIVE This proposal requests sponsorship for a unique training program, the US Ten-Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases (CVD) and Stroke, which was established in 1975, and offered annually since. Given the immense burden of CVD and stroke to this nation in terms of disability, death, disparities, and costs, this focus area is highly appropriate as a setting for professional training in research and dissemination of evidence supporting improved prevention and patient outcomes. Securing availability of such a workforce is in line with the NHLBI’s strategic vision, is a key element of our country’s readiness to address the public health and medical challenges posed by CVD; and is critical to our readiness to advance multi-component strategies that promote cardiovascular health for all.